6/11 Astrocyte-specific changes and interventions in alcohol dependence

PROJECT SUMMARY
Astrocytes respond to CNS damage and disease with changes in gene expression and morphology and with
immune activation to become reactive astrocytes. Alcohol Use Disorder is characterized in part by
neuroimmune responses that increase with the progression of the disorder. Reactive astrocytes upregulate the
expression of Tissue-type Plasminogen Activator (tPA) encoded by the gene Plat, which is involved in brain
plasticity, the remodeling of the brain extracellular matrix, and neuroimmune responses including microglial
activation and neuroinflammation. tPA is upregulated by ethanol in several brain areas and in astrocytes in
several models of ethanol exposure. The main scientific questions driving the proposed studies are: 1) What
are the changes in translating RNA occurring in astrocytes after Chronic Intermittent Ethanol-2 Bottle Choice
(CIE-2BC)? 2) What are the changes in nuclear gene expression occurring in astrocytes after CIE-2BC? 3)
Does Plat/tPA knock-down in astrocytes reduce escalation in drinking, neuroimmune responses, and synaptic
changes induced by CIE-2BC? We hypothesize that: CIE-2BC induces changes in the translation of
neuroimmune genes in astrocytes and that some, but not all, changes in translation are driven by changes in
transcription. We also hypothesize that knocking down Plat selectively in astrocytes will attenuate escalation in
drinking, induction of neuroimmune genes, and synaptic changes induced by CIE-2BC. We propose to use the
Aldh1l1-EGFP-Rpl10a mouse model that allows the selective pull down of actively translating RNA from
astrocytes by the translating ribosome affinity purification (TRAP) method. Moreover, this mouse line has GFP
fluorescence in the nucleus that allows for the isolation of astrocyte-specific nuclei by Fluorescent-Activated
Cell Sorting (FACS). In Specific Aim 1 we will study the translatome in amygdala and PFC of female and male
Aldh1l1-EGFP-Rpl10a mice after CIE-2BC by TRAP-RNA-seq. Pathway analysis will be performed to
determine enrichment in the biological processes affected by CIE-2BC. We will employ TRAP-qPCR, Western
blot, and immunohistochemistry (IHC) to validate changes in neuroimmune gene translation and protein
expression. In Specific Aim 2 we will study the nuclear transcriptome in the amygdala and PFC of female and
male Aldh1l1-EGFP-Rpl10a mice after CIE-2BC by FACS sorting of astrocyte nuclei followed by RNA-seq. We
will integrate transcriptome and translatome data to identify RNAs regulated by alcohol through transcription-
dependent and transcription-independent mechanisms. We will employ FACS-qPCR and Fluorescence In Situ
Hybridization (FISH)-RNAScope to validate changes in neuroimmune gene expression. In Specific Aim 3 we
will investigate the hypothesis that tPA knock-down in astrocytes attenuates CIE-2BC-induced escalation of
drinking, immune response, and synaptic changes. Inducible Aldh1l1-Cre/ERT2 mice will be crossed to floxed
Plat mice for the selective knock down of Plat in astrocytes. Mice lacking tPA in astrocytes will undergo CIE-
2BC; drinking escalation, immune response, and synaptic changes will be assessed.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health and to the NIAAA's mission because it employs novel approaches to investigate neuroimmune factors expressed by astrocytes (understudied brain cells that are essential for the proper functioning of the brain) in an animal model of alcohol dependence. The proposed studies will provide insights on how alterations in astrocytes result in increased inflammation leading to increased alcohol drinking. The aforementioned insights, obtained using and clinical genetically engineered animal models emerging “-omic” approaches in a cell-type specific manner (astrocytes), will provide new mechanistic and understanding of the impact of astrocytes in alcohol dependence andwill lead to therapeutic interventions that are not only specific for a given molecular target, but also for a given cellular target and, for this reason, safer.